Elucidating the Molecular and Functional Diversity of Axial Motor Neurons

Project Summary/Abstract
The axial neuromuscular system plays a critical role in many essential motor behaviors in mammals, including
breathing, postural stability, and integration of movement by the trunk and limbs. While the mechanisms that
allow for molecular and functional diversification of limb innervating motor neurons (MN) have been relatively
well characterized, less is understood about how axial motor circuits are specified during development. Further,
it is not well understood whether axial MNs exist in discrete pools that innervate distinct muscle populations to
achieve motor activities through activation of specific muscles. It is also not known whether the molecular
identities of axial motor neurons are related to a set of functional properties in tetrapods, nor if these molecular
identities dictate the connectivity patterns of spinal premotor interneurons that modulate activity of downstream
muscle targets. The proposed work in this study seeks to elucidate the fate determinants that govern organization
of molecularly distinct populations of motor neurons within the medial motor column (MMC). In Aim1, I will
characterize the molecular subtypes and anatomical organization of MMC neurons. I will use single nuclear (sn)
RNA-seq to define the molecular diversity of MMC MNs in mouse embryos. I will then use immunohistochemistry
(IHC) and hybridization chain reaction RNA-FISH (HCR) to further characterize the anatomical organization of
molecularly defined MNs. I will also use retrograde tracing in embryos and early postnatal mice to determine
whether molecularly unique populations of MMC neurons correspond to motor pools. Aim 2 explores the role of
fate determinants in axial MN diversity and muscle target specificity. I will use snRNA-seq, IHC and HCR to map
the molecular diversity and organization of MMC MNs in mice with mutations in three classes of fate
determinants, Mecom/Prdm16, Satb2, and Lhx3/4. Further, I will use mice that co-express the Hb9-GFP reporter
to assess the pattern of axial muscle innervation. Finally, to define the epistatic relationships between these
transcription factors in the MMC gene network, I will use chick neural tube electroporation to misexpress Mecom,
Satb2 or Lhx3 in all MNs and examine the impact on axial MN specification. Aim 3 seeks to elucidate the role of
MMC molecular identity in axial circuit assembly and function. I will use monosynaptic rabies tracing to define
the distribution of spinal premotor inputs targeting MMC in control and mutant mouse models. I will also perform
motorized treadmill assays while recording muscle activity from epaxial muscle, in addition to capturing gait and
posture during locomotion. This work will provide an understanding of how axial motor systems are developed,
their functions, the molecular identity of unique axial motor pools, and the role of fate determinants in specifying
circuits that dictate the function of axial muscle. Understanding this is essential to our understanding of the
function of axial MNs and their larger role in spinal cord injury and disease. Further, this project could serve as
a model for childhood developmental disorders such as scoliosis.

Public health relevance
Project Narrative The primary goal of this project is to investigate the molecular mechanisms involved in the assembly of spinal circuits governing posture and locomotion. This study will explore the role of cell fate determinants in establishing synaptic specificity in the axial neuromuscular system and determine how developmental programs contribute to the emergence of specific motor behaviors. Defining the pathways that regulate axial motor circuit development provide basic insights relevant to the study of diseases that affect motor control, including developmental disorders in humans such as scoliosis.